Structure-function of the α4β2 nicotinic acetylcholine receptor in a lipidic environment

Project summary (1-2 para): Nicotinic acetylcholine receptors are ligand-gated ion channels that are widely expressed throughout the central and peripheral nervous systems. The α4β2 nicotinic receptor is the most abundant subtype in the brain and is linked to nicotine addiction and neurological disorders including Alzheimer's and Parkinson's diseases. Expression of the α4β2 receptor is upregulated by chronic exposure to nicotine in vitro and in the brains of smokers compared to that of non-smokers. Accordingly, there have been extensive efforts to develop small molecules to reduce tobacco addiction by targeting this receptor type, but these efforts are hampered by the limited amount of structural information for nicotinic receptors. Atomic structures of a desensitized-state nicotinic receptor in detergent obtained by X-ray crystallography and Cryo-EM are known, but high-resolution structures in a physiologically relevant lipidic environment remain unresolved. Moreover, we lack structural information for this receptor in the different states along the gating cycle. Here I propose to first identify combinations of lipids that support robust channel function using electrophysiological approaches. In parallel I will optimize sample preparation for the α4β2 nicotinic receptor in lipidic nanodiscs, leveraging the information from the functional studies in defined lipidic environments. I will use these preparations to obtain high resolution structural information for the α4β2 nicotinic receptor in distinct conformational states, in an experimental condition tied directly to a physiological preparation. Structural information for the receptor in a membrane and in different conformational states will provide touchstones for understanding allosteric gating of these receptors and templates for development of state-selective pharmacological tools and therapeutics.

Public health relevance
Project Narrative According to research from the U.S. Department of Health and Human Services, cigarette smoking causes over 480,000 deaths per year in the US. This research project aims to understand at a fine level of detail how nicotine binding to its site in the brain triggers the first steps in the process that ultimately leads to nicotine addiction. Success in the proposed research will promote a better understanding of the nicotine receptor and will provide a basis for improved pharmaceuticals for nicotine addiction and neurological disorders.